Cortical neuromodulatory mechanisms underlying adaptation and plasticity

PROJECT SUMMARY
During our previous studies, we established synaptic zinc as a powerful neuromodulator of synaptic
transmission, synaptic plasticity, and sound processing. Based on these findings and our preliminary results, we
propose that cortical synaptic zinc is a crucial neuromodulator for cortical adaptation and plasticity (recovery)
after noise trauma (peripheral damage). Namely, we plan to answer two main questions: 1) What are the cell-
type-specific zincergic neuromodulatory mechanisms underlying cortical adaptation to different background
sound statistics? And 2) How do cell-type-specific zincergic neuromodulatory mechanisms contribute to cortical
and perceptual recovery after peripheral damage? Answering these questions will advance the field to a new
level of understanding about cortical neuromodulatory mechanisms during normal and pathological sensory
processing, and create a new framework for approaching and interpreting cortical adaptation and plasticity.
Importantly, our proposed studies hold the potential to highlight novel strategies for enhancing hearing after
hearing loss, and for mitigating disorders that are associated with maladaptive central plasticity after peripheral
damage, such as hyperacusis and tinnitus

Public health relevance
PROJECT NARRATIVE This research will test several novel hypotheses regarding the interactions between synaptic zinc, glutamate, GABA, NMDA receptors (NMDARs), AMPARs and GABARs. These interactions are fundamental to our understanding of synaptic transmission and synaptic plasticity, as well as sound processing in health and hearing loss. Because these processes are found in many brain areas and are associated with several disorders, such as epilepsy, hyperekplexia, autism, schizophrenia, Alzheimer’s disease, hearing loss, tinnitus and pain processing, this research is relevant to those aspects of the NIH mission aimed at improving health through understanding pathophysiological mechanisms in disorders causing disability.